Early life effects on later life health and aging: molecular mechanisms and context-dependency

Project Summary
Early life adversity (ELA) is associated with an increased later life risk of many of the most common diseases of
aging, including cardiovascular, autoimmune, and neurodegenerative diseases, as well as premature mortality.
However, the mechanistic basis of ELA effects on age-related outcomes remains poorly understood, limiting our
ability to design effective therapeutic or intervention strategies. At the molecular level, ELA effects on later life
physiological processes are thought to be mediated by stable changes in gene regulation. However, for practical
and ethical reasons, work in this area in humans has been restricted to a handful of sample types (e.g., saliva,
circulating blood cells). As a result, we lack a comprehensive understanding of the relationship between ELA
and gene regulation across the many organ systems and contexts that are involved in aging-related diseases. I
will address this gap by studying ELA effects on tissue- and context-specific gene regulation in an established
primate model of aging: the free ranging rhesus macaques of Cayo Santiago. To do so, I will leverage genome-
wide DNA methylation and gene expression data that are currently being generated across 15 tissues collected
from 100 previously euthanized adults. Longitudinally collected demographic and behavioral data are available
for the same individuals, which will allow me to compile ELA measures with close correlates in humans, and to
explore the impact of ELA on tissue-specific epigenomic and transcriptomic function (Aim 1). Additionally, I will
perform new experiments to measure genome-wide gene expression in blood cells before and after exposure to
5 proinflammatory molecules (n=100 individuals); these data will allow me to test the hypothesis that ELA has
especially strong effects on immune gene regulation when cells are pushed to a proinflammatory state. I will
focus on this cellular context because chronic inflammation is a hallmark of most diseases of aging (Aim 2).
Finally, using data from Aims 1 and 2, I will perform follow up analyses to understand inter-individual variation in
the response to ELA, namely whether sex modifies ELA effects on gene regulatory variation. At its conclusion,
this project will provide the most comprehensive picture to date of the tissue and context-specific nature of ELA
effects at the molecular level. It will do so using a well-established primate model, which circumvents reporting
biases and confounds inherent to human ELA studies while still providing a necessary, naturalistic
socioecological context for understanding early experiences. Further, by leveraging a primate model, I will be
able to address how ELA becomes embedded into lifelong molecular and physiological processes across a suite
of tissues that are near impossible to sample at scale in humans but are relevant to the most prevalent disease
of aging (e.g., brain, heart, adipose). Together, this work will advance our understanding of how gene regulatory
mechanisms function to embed early life insults into long-term physiological memory in aging adults.

Public health relevance
Project Narrative Challenging physical or social experiences in early life can have long-lasting effects on health and aging. The proposed work will leverage a well-established, non-human primate model to investigate the gene regulatory mechanisms that underlie this relationship across 15 tissues as well as 6 cellular proinflammatory contexts—all of which are extremely relevant to aging but are understudied for ethical and practical reasons. In doing so, this work will greatly expand the scope of our understanding of how early life experiences become “embedded” into lifelong physiology, thereby improving our ability to design effective therapeutic or intervention strategies.